Prevention and Treatment of Pneumocystis Pneumonia

The fungal opportunistic pathogen, Pneumocystis (Pc) jirovecii is the causative agent of Pneumocystis
pneumonia (PCP), which is of increasing concern in persons receiving immunosuppressive therapies, including
organ transplant recipients, cancer patients, individuals with inflammatory disease and in persons experiencing
natural immunosuppression due to aging, congenital or acquired immunosuppressive states. In addition, in
clinical studies and in non-human primate models, we have shown that persistent Pc colonization is also
associated with the development of chronic obstructive pulmonary disease (COPD). Long-term goals of our
work are to develop vaccine strategies for the prevention of Pc infection and related pulmonary
sequelae in immunocompromised populations and to develop innovative strategies for improved
therapies for acute PCP in immunocompromised individuals. To achieve these goals, we have developed
pre-clinical, non-human primate models of PCP in drug-induced immunosuppressed animals. We have
previously identified a recombinant protein sub-unit vaccine, KEX1, that induces robust anti-Pc immunity in
non-human primates that is durable and protective against PCP following profound immunosuppression
induced by simian immunodeficiency virus infection (SIV) and reported that antibodies to KEX1 are associated
with prevention of PCP in human immunocompromised individuals. The objectives to be addressed in the
proposed studies are 1) to determine the protective efficacy of the KEX1 vaccine in pre-clinical models of
therapeutic immunosuppressive regimens, (e.g., as in organ transplantation) and 2), to harness our extensive
data regarding the protective nature of the humoral responses to KEX1 for the development and testing of
monoclonal antibodies (mAb) for use in treating acute PCP. We hypothesize that the KEX1 vaccine will induce
durable and protective immunity against PCP in immunocompromised individuals. We further hypothesize that
treatment of acute PCP with KEX1 mAbs will contribute to resolution of pneumonia and mitigate pulmonary
damage associated with the infection. Aim 1 will test the hypothesis that immunization with KEX1 vaccine will
elicit protective memory responses and will provide protection from PCP in immunocompromised NHPs. We
will evaluate the durability and protective efficacy of the immune response during immunosuppressive therapy.
NHPs will be challenged via natural exposure to Pneumocystis and evaluated for clinical disease, immunity,
pulmonary function and pathology. Aim 2 will test the hypothesis that KEX1-specific mAbs will effectively treat
established PCP in an immunosuppression NHP model. Our innovative technology in mAb generation,
combined with a unique and clinically relevant model of PCP in immunosuppressed monkeys, will allow us to
define the utility of KEX1 mAbs in treating PCP and advance a novel therapeutic avenue for this disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: Pneumocystis jirovecii is the causative agent of Pneumocystis pneumonia (PCP), which remains a life-threatening illness of increasing concern in individuals with weakened immune systems. The research proposed research will further advance a vaccine candidate and immune-therapeutic for the prevention and treatment of PCP in immunocompromised individuals. The successful completion of these studies will advance these vaccine candidate and immunotherapeutics toward clinical trials.